COLLECTING WHOLE GENOME SEQUENCE DATA TO ENHANCE THE VALUE OF THE FIRST MULTI-CENTER STUDY OF COLORECTAL CANCER RISK FACTORS AND BIOLOGY IN NIGERIA

COLLECTING WHOLE GENOME SEQUENCE DATA TO ENHANCE THE VALUE OF THE FIRST MULTI-CENTER STUDY OF COLORECTAL CANCER RISK FACTORS AND BIOLOGY IN NIGERIA